ORAL VS INTRAVENOUS CORTICOSTEROIDS IN TOXICITY OF OPTIC NEURITIS

This study will assess (1) if treatment of acute optic neuritis with oral or intravenous corticosteroids reduces residual visual dysfunction present following resolution, (2) if corticosteroids speed recovery of visual function, and (3) if complications of corticosteroid treatment are insignificant as compared with the magnitude of treatment effect.